Development of Mirror-Image Natural Products as Antiarrhythmic Therapeutics

Project Summary
This program focuses on the development of a new class of antiarrhythmic agents that normalize
dysfunctional RyR2 channels, the calcium release channel in the sarcoplasmic reticulum
(intracellular) membrane. Human RyR2 mutations cause two distinct genetic arrhythmia
syndromes: (i) Catecholaminergic Polymorphic Ventricular Tachycardia (CPVT) due to RyR2 gain
of function mutations, and (ii), Calcium Release Deficiency Syndrome (CRDS) due to RyR2 loss
of function mutations. RyR2 gain of function due to post-translational modifications has been
implicated mechanistically in heart failure and atrial fibrillation. RyR2-selective modulators are
lacking. The overarching goal of this transdisciplinary program is the selection of antiarrhythmic
clinical candidates based on ent-verticilide, a potent inhibitor of RyR2-mediated calcium release
in cardiomyocytes. Preliminary data for this first potent and selective inhibitor include efficacy in
several models of disease, and PKPD in a chronic dosing study. Our collective results support
the rationale that selective therapeutics can improve our understanding of RyR2 biology and lead
to preclinical candidates. Since ent-verticilide is not a natural product, all compounds must be
obtained by de novo chemical synthesis. Chemical synthesis has provided renewable access to
drug, and served as a platform for rapid analog development to support pharmacology studies. A
comprehensive study of verticilides for therapeutic development is outlined in three Aims. Aim 1
describes the use of cryo-EM and photocrosslinking studies to further elucidate mechanism of
action and create a platform for structure-guided design. The goal of Aim 2 is to increase the
bioavailability of ent-verticilide and test efficacy of oral dosing in atrial fibrillation and heart failure
models. Aim 3 describes lead backup development using ent-verticilide B1, an 18-membered ring
oligomer. A strength of this approach is its ability to adapt to changes in the state of the art in
RyR2 structural biology, an effort to which we will contribute (Aim 1). Highly potent and selective
compounds will be advanced to in vivo safety and efficacy studies (Aim 2) with backup lead
identification to de-risk the overall program. This program is highly collaborative and
transdisciplinary in nature, and the studies will advance a novel class of compounds never-before-
used in therapeutic development. Preliminary results have already advanced our understanding
of RyR2 molecular pharmacology and promise new antiarrhythmic agents to improve human
health.

Public health relevance
Project Narrative This transdisciplinary, collaborative research program develops the finding that a mirror-image natural product is the first potent and selective inhibitor of RyR2, a protein found largely in cardiac tissue. Dysregulation of RyR2 can lead to ventricular arrhythmias that account for 10-20% of all deaths in adults in the US. The proposed work will prepare analogs to examine the mechanism of action and achieve the needed efficacy and safety profiles required to select optimal leads for preclinical development for dysregulated RyR2 function.